Molecular Structural Basis of Non-specific Neuronal Membrane Disruption Induced by Early-Stage Beta-Amyloid Peptide Aggregation

Abstract
Non-specific disruption of neuronal cell membrane induced by amyloidogenic aggregation of b-amyloid
(Ab) peptides is considered a viable mechanism in the pathology of Alzheimer’s disease (AD). Understanding
the structural basis of key molecular interactions that are responsible for the membrane disruption remains
challenging, mainly due to the heterogeneity nature of Ab-membrane systems and the low abundance of key
intermediate states. High-resolution solid-state nuclear magnetic resonance (ssNMR) spectroscopy provides the
most powerful method for studying the membrane-disruptive Ab aggregation in its native-state-mimicking
environments, i.e., in model liposomes and/or in the presence of neuronal cells.
Our long-term goal is to understand the structural basis of key Ab-membrane interactions that are
responsible for the non-specific membrane disruption in neurons. During the last funding period, my group has
demonstrated the generality of two distinct membrane-disruptive processes in model liposomes: local membrane
leaking induced by on-fibrillation-pathway Ab intermediates and membrane fragmentation induced by off-
fibrillation-pathway large Ab oligomers. We have also established ssNMR approaches to investigate the
structural features and molecular interactions at the intermediate states of individual processes. These ssNMR
measurements allow systematic studies of time-dependent structural changes of Ab aggregates and key Ab-lipid
interactions in the time frame of membrane disruption process, as well as the modulations of lipid dynamics due
to the Ab amyloidosis. In addition, we are exploring the feasibility for extending the studies from membrane-
mimicking liposomes to neuronal cells, by using a multipronged strategy combining in-cell ssNMR spectroscopy
with cellular imaging/viability assays/quantitative analysis.
The current renewal proposal contains three aims. Aim 1 and 2 seek for finalizing the mechanistic studies
of membrane-disruptive Ab interactions in liposomes. Specific mechanistic models are proposed and will be
demonstrated using extensive ssNMR experiments, including advanced sensitive-enhancing dynamic nuclear
polarization (DNP) ssNMR techniques. Key membrane-interruptive intermediate states (including Ab structural
features, lipid dynamics and Ab-lipid interactions) will be elucidated. In Aim 3, we strive to developing in-cell
ssNMR approaches and quantitative cellular assays/analysis for probing the molecular basis of Ab-induced
cellular membrane disruption. This involves identification of Ab-induced membrane-disruptive intermediate
states with neuronal cell lines and establishment of in-cell 31P and DNP-assisted ssNMR spectroscopy, including
the optimization of sample conditions and spectroscopic methods. Outcomes from the current period, including
both the understanding the membrane disruptive effects and the development of ssNMR-based methods, will
pave the way for future studies in primary neurons.

Public health relevance
Project Narrative This project explores the structural basis of key molecular interactions that are responsible for the cellular membrane disruption induced by amyloidosis of b-amyloid peptides. The outcomes will provide insights on the pathological roles of both Ab amyloidogenic aggregates and cellular plasma membranes in Alzheimer’s disease.